Bridging stochastic and deterministic paradigm of olfactory receptor choice in ants

Project Summary / Abstract
Gene families include up to hundreds of highly similar sequences that may perform related but non-
redundant functions. Therefore, understanding how the correct gene is activated at the appropriate location
and time remains an important question. Odorant receptor (Or) genes present a particularly prominent example
of this problem. Previous research in mice (which have >1,000 Ors) and flies (which have 60 Ors) led to an
idea that large Or families employ stochastic gene choice, while small Or families follow deterministic
specification. The jumping ant Harpegnathos saltator lies in between these extremes, possessing 376 Or
genes, most of which are not interspersed throughout the genome, but located within tandem genomic arrays
that contain up to 58 genes each. This proposal will test a model where each olfactory sensory neuron (OSN)
in ants expresses a single locus, either a single gene or an array, using the same deterministic mechanism as
Drosophila melanogaster to choose between a limited number of loci. Single gene loci are expressed
deterministically, while loci that contain multiple genes have an added stochastic mechanism by which a single
Or promoter is chosen out of the array. To this end, I performed single-nucleus RNA-seq (snRNA-seq) on the
H. saltator antennae. Strikingly, although isolated genes were uniquely expressed in non-overlapping sets of
OSNs, genes within arrays were co-expressed. In all such cases, they followed a highly stereotypical pattern:
given genes A, B, C within an array, either C (the most 3’ gene) was expressed alone in some OSNs, or B and
C were co-expressed in another subset of OSNs, or all three genes were expressed concurrently in yet
another subset. In addition, the snRNA-seq data revealed extensive antisense transcription in these loci. The
antisense RNAs covered genes upstream of the first transcribed gene and appeared to originate from the
same promoter. Thus, the antisense RNAs are mutually exclusive with the sense RNAs, suggesting that the
antisenses may repress the transcription of genes upstream of the chosen promoter. In aim 1, I will investigate
the mechanisms of the co-transcription among clustered genes, determine whether co-transcribed genes are
co-translated and whether OSNs that express them target distinct glomeruli in the brain, identify sequence
features that enable transcription and provide stability to the antisense RNAs, and test the potential repressive
function of the antisense transcripts. Together, this will provide a comprehensive description of the
transcriptional mechanisms of the single gene choice in H. saltator Or arrays and uncover how this translates
into protein expression. In aim 2, I will determine the transcription factor code associated with each Or gene,
collect chromatin interaction and multiome (snRNA-seq paired with ATAC-seq) data to comprehensively
identify putative regulatory regions, determine whether one or both alleles are expressed in each cell, and test
the function of the candidate enhancers. Together, this will uncover the regulatory architecture of the Or loci,
potentially revealing a novel stochastic mechanism of promoter choice within arrays.

Public health relevance
Project Narrative During development, each olfactory sensory neuron needs to choose a single odorant receptor (Or) out of a large family of similar genes, and previous research in mice (which have >1,000 Ors) and flies (which have 60 Ors) produced an idea that large Or families employ stochastic gene choice, while small Or families follow deterministic specification. The jumping ant Harpegnathos saltator lies in between these extremes, possessing 376 Or genes, most of which are not interspersed throughout the genome, but located within tandem genomic arrays that contain up to tens of genes. In this proposal, I will test a model where each olfactory neuron in ants expresses a single locus, either a single gene or an array, using the same deterministic mechanism as Drosophila, followed by a novel mechanism of stochastic promoter choice within the arrays.